Study of tyrosine kinase inhibitors as preventive therapy in RUNX1-FPD

Abstract
Familial platelet disorder (FPD) is a rare, inherited, dominant disease that is associated with high lifetime-risk
of developing hematologic malignancies. FPD patients can live for decades in a “pre-leukemic” period before
disease onset, opening a therapeutic opportunity for the development of preventive treatments. Molecularly,
FPD is caused by germline mutations in the RUNX1 gene that reduce RUNX1 function, and is associated
with clonal hematopoiesis and deregulated cytokine production in the immune system. Our preliminary results
show that germline Runx1 mutations in mice create a pre-leukemic bone marrow niche marked by increased
inflammatory cytokines, reduced DNA damage repair (DDR) response, and predisposition to hematologic
malignancies. Furthermore, we found that treatment with the tyrosine kinase imatinib restored DDR response
in vitro. Based on these preliminary data, we hypothesize that RUNX1 mutations hamper DDR response in
hematopoietic stem and progenitor cells thereby promoting clonal hematopoiesis and the risk to developing
hematologic malignancies. Furthermore, we propose that treatment with the tyrosine kinase inhibitor imatinib
reduces clonal selection and may prevent disease onset by restoring DDR response. This hypothesis will be
tested in the following three Specific Aims: 1. Determine the efficacy of the tyrosine kinase imatinib in restoring
DDR response in human FPD pre-malignant cells. 2. Identify and characterize the pathways targeted by
imatinib treatment in DDR of RUNX1-mutant hematopoietic cells. 3. Study the efficacy of tyrosine kinase
inhibitors in preventing FPD-associated hematologic malignancies in mice. Together, these studies will
provide mechanistic and functional insights into the role of RUNX1 mutations in DDR pathways, clonal
selection and predisposition to hematologic malignances. Furthermore, they will establish whether treatment
with tyrosine kinase inhibitors can reduce clonal selection and delay the onset of hematologic malignancies.
These results may have a direct impact on the initiation of a phase-II clinical trial for FPD patients.

Public health relevance
Narrative Individuals with a germline mutation in the gene RUNX1 have “Familial Platelet Disorder”, a blood disease that confers high risk for developing blood cancer in life, and for which current treatments are limited to chemotherapy and stem cell transplantation from a matching donor. In this grant application, we will study the cellular mechanisms that drive cancer risk, and whether imatinib, a drug that has been successfully used for the past 20 years in the treatment of chronic leukemia, can prevent or delay the development of blood cancer. If successful, this study will uncover mechanistic and functional insights into predisposition to blood cancers for these patients, and serve as proof-of-principle evidence in support of the use of imatinib in a phase-II clinical trial application as preventive therapy for Familial Platelet Disorder.